Molecular mechanism of polyamines on DNA dynamics during DNA repair

PROJECT SUMMARY
Polyamines (PAs) are positively charged, branched small molecules that are ubiquitous throughout the cell,
heavily concentrated within the nucleus, and are frequently found bound to negatively charged nucleic acids and
proteins. PAs play regulatory roles within the cell due to their ability to bridge molecules intra- and intermolecularly,
leading to the condensation and compaction of DNA, nucleosomes, and chromatin. Despite their small size, PAs
participate in genomic spatial and topological organization, playing roles in genome integrity and gene
expression. With Parkinson’s disease, polyamine homeostasis is perturbed. In addition, DNA damage levels are
elevated and are not efficiently repaired, eventually leading to neurodegeneration and cell death.
This study will investigate and determine the molecular mechanism of polyamines on DNA dynamics during DNA
repair by homologous recombination (HR). It will utilize in vitro single-molecule and bulk solution assays to
assess the extent to which PAs impact the flexibility and dynamics of single-stranded, double-stranded, and non-
canonical DNA structures to understand how PAs can impact the dynamics of their formation and accumulation
(Aim 1). The in vitro assays will be extended by adding RAD51 to understand the role of PAs in protein-DNA
interactions and their impact on RAD51-mediated strand exchange and repair (Aim 2). This will be followed by
live cell fluorescence microscopy and chromatin immunoprecipitation sequencing of RAD51-mediated repair in
a PA-dependent manner to visualize and quantify the role of PAs in DNA damage repair (Aim 3).
The combination of Sua Myong and Taekjip Ha will foster a strong training environment. The Myong lab is one
of the leaders in studying non-canonical nucleic acid conformations and protein-nucleic acid interactions
leveraging novel single-molecule and cellular approaches. The Ha lab is also a leader in visualizing and
quantifying genome maintenance and mechanics by developing and using fluorescence imaging approaches in
cellulo combined with CRISPR technology. The mentorship team of both Sua Myong and Taekjip Ha will cover
the biophysical and genome topics necessary to build a strong academic career in tackling health questions
through a basic science research lens.

Public health relevance
PROJECT NARRATIVE Polyamines such as spermine and spermidine are small, positively charged, branched molecules ubiquitous throughout the cell that play numerous roles in maintaining healthy cellular function, but they have been difficult to study due to their ability to bridge DNA and other biomolecules. In this study, we will investigate how polyamines impact DNA flexibility and dynamics, which affects damage susceptibility and repair accessibility. Information gained from the proposed research will be used to further understand the role of polyamines in DNA dynamics and damage repair processes in the context of aging with implications for polyamines as biomarkers.